Control of bacterial infections by a horizontally acquired host peptidoglycan amidase

ABSTRACT
Ticks are obligate blood-feeding arthropods that transmit numerous pathogens to both humans and
livestock. Lyme disease, which is caused by transmission of the spirochete Borrelia burgdorferi by the deer
tick Ixodes scapularis, is responsible for over 95% of vector-borne disease cases in the United States. Despite
the importance of ticks as disease vectors, elucidating the molecular basis for tick–pathogen relationships has
lagged due to our incomplete understanding of tick innate immunity. We recently identified an antibacterial
enzyme in I. scapularis that was co-opted from bacteria through horizontal gene transfer. This domesticated
amidase effector (dae2) gene encodes an active, bacteriolytic cell wall hydrolase that is enriched in the gut and
salivary glands of ticks. We found that Dae2 affords previously uncharacterized antibacterial activity to the
innate immune system of ticks and propose to investigate its role in shaping tick–microbe interactions and
vector competence for the Lyme disease pathogen B. burgdorferi. This work will advance our fundamental
understanding of how ticks have evolved to selectively control bacteria they transmit and potentially offer new
avenues for blocking the tick-borne cycle of infection for an important human pathogen.

Public health relevance
PROJECT NARRATIVE Ticks are blood-feeding arthropods that transmit most zoonotic diseases in the United States. Although interactions between ticks and bacterial pathogens can be highly specific, very little is known about vector host factors that modulate tick–microbe interactions. This proposal aims to define the mechanism of a novel antibacterial effector of the innate immune system of the deer tick Ixodes scapularis, which transmits the causative bacterial agent of Lyme borreliosis.